Administrative and Faculty Development Core

Project Summary
This new Phase I Center of Biomedical Research Excellence (COBRE) proposal will develop a new
interdisciplinary research Center within the University of Nevada, Reno (UNR), and the UNR School of Medicine
(UNR Med) that is focused on fundamental molecular and cellular signal transduction mechanisms in the
cardiovascular system. Core A, the Administrative and Faculty Development Core, is described here. Core A will
provide management in administrative, fiscal, and scientific aspects of the COBRE. Core A will be directed by
Dr. Scott Earley, Professor of Pharmacology at UNR Med, the Principle Investigator and COBRE Director. Dr.
Earley is an accomplished investigator with an established track record of NIH R01 funding, publication in high-
quality journals, and committed to mentoring young scientists. The following goals have been established for
Core A during Phase I: 1) Provide scientific leadership and develop an administrative structure for the Center;
2) Execute an aggressive Faculty Development Plan to provide personalized, one-on-one mentoring for the
COBRE’s Project Leaders. The Faculty Development Plan is designed to transition the Project Leaders from
early career investigator status to fully independent research scientists funded by their own Research Project
Grants (RPGs), such as an NIH R01 or equivalent; 3) Establish and monitor milestones for evaluating the
progress of Project Leaders toward scientific independence. 4) Select and recruit new Project Leaders to replace
those who graduate; 5) Promote collaborations among graduated Project Leaders and established investigators
within the Center to develop collaborative RPGs and new Program Project Grants that will enhance the long-
term sustainability of the Center; 6) Implement a formative and summative evaluation strategy for the COBRE,
the Project Leaders, and the Research Cores with specific milestones. Successful completion of these goal will
establish the Nevada COBRE in Molecular and Cellular Signal Transduction in the Cardiovascular System as
an internationally recognized, sustainable multidisciplinary research Center investigating the regulation of
cardiovascular function during health and disease.

Public health relevance
Project Narrative This goal of this proposal is to establish and develop the Administrative and Faculty Development Core (Core A) of a new Phase I Center of Biomedical Research Excellence (COBRE) that is focused on molecular and cellular signal transduction in the cardiovascular system within the University of Nevada, Reno (UNR), and the UNR School of Medicine. Core A will establish the infrastructure to manage administrative, fiscal, and scientific aspects of the COBRE; establish and execute a Faculty Development Plan to promote the rapid development of the COBRE’s Project Leaders from early stage investigators to fully independent research scientists; continuously track and evaluate the progress of Project Leaders to scientific independence; and evaluate the success of the Research Cores.